Investigation of the Properties of Liquids in the Porous Networks of Macromolecular Crystals

Abstract
Knowledge of macromolecular structure is important for understanding and developing treatments for
a diverse array of diseases. Many macromolecular structures are determined via diffraction
techniques, for which a key step is to grow crystals of the macromolecule of interest. The crystals are
highly packed nanoporous materials in which an ordered array of biological macromolecules is
permeated with a network of nanometer-sized pores. The long-term goal of this project is to
understand the interplay between the macromolecules and the liquid inside the pores and how this
affects the response of the crystals and their substituent macromolecules to changes in external
environment such as temperature and solution conditions. This is important for two main reasons.
First, macromolecular crystals often undergo changes in their environmental conditions as part of
their analysis. Second, the interplay between the macromolecules and solvent is key in understanding
functional aspects of the macromolecules, not only in crystals but also in the similarly highly packed
environment of the cell. Here we focus on how the environment of the porous network affects the
properties of the liquid inside. By using single particle fluorescence tracking, we will measure diffusion
of probes within the porous network of macromolecular crystals. Comparing these results to
diffraction experiments will elucidate the diffusion and flow characteristics of the liquid in the pores.
Hence information that can lead to more gentle treatment of these delicate samples will improve the
overall quality of structure determined via crystallography and better understanding of the behavior of
liquids in highly packed environments. The long-term effects of improved understanding of the
response of macromolecular crystals to changes in environment will be to ensure that the highest
quality diffraction possible is recorded from each crystal. This will (a) improve the average quality of
structures determined by X-ray crystallography and (b) make the more difficult crystallographic
problems more tractable. This work will impact public health by improving the reliability of biological
interpretations based on macromolecular structures, and will increase the likelihood that the structure
of any particular molecule with a potential impact on health can be efficiently determined. In the long
term, this would improve our understanding of the causes of, and facilitate treatments for, diseases
resulting from the alteration of macromolecular structure and function by either genetic or
environmental factors.

Public health relevance
Narrative This project will improve understanding of the behavior of fluids in the packed environments of macromolecular crystals. In the long term this will improve the quality of three-dimensional structures of macromolecules determined with macromolecular crystallography. These structures are key for understanding the molecular basis of disease and higher quality structures provide more accurate information for developing therapies to improve human health.